Exploiting Public Metagenomic Data to Uncover Cancer-Microbiome Relationships

Abstract
Dysbiosis of the host microbiome is now recognized as a hallmark of cancer and a factor in the systemic
response to immunotherapy. While a large volume of literature and data resources on microbiome research are
available, systemic comparison and analysis are limited due to the heterogeneity in data and reporting
schema. To enable rapid and cost-effective elucidation of the roles of microorganisms in the etiology and
progression of cancer, we have developed high-quality harmonized databases of public microbiome data and
microbial signatures. This proposal expands and creates new features of these microbiome databases through
four aims. First, it will enhance the analytic scope of BugSigDB, a Semantic Mediawiki for manual curation and
review of microbial signatures by incorporating microbial physiologies and morphologies, predicted metabolic
functions, automatic identification of similar signatures, and creation of user-friendly Bug Set Enrichment
Analysis workflows. Second, it will establish the next generation of curatedMetagenomicData, a microbiome
database of large-scale manual curation and uniformly processed shotgun sequencing data, supporting FAIR
principles. We will create a federated, ontology-based curation system and distributed computing metagenomic
profiling workflow, both applicable to all Sequence Read Archive (SRA) records. Third, it will expand
curatedMetagenomicData and BugSigDB with data from thousands of published studies and perform
meta-analyses using these resources. Lastly, we will mobilize hundreds of data curators from diverse
backgrounds by participating in established internship programs and mobilize the microbiome research
community to adopt reporting standards for publication. This contribution is significant because it increases the
likelihood of developing effective public health interventions to prevent and detect microbiota-linked cancers by
providing methods for improved mechanistic interpretation of microbiome studies, extracting new information
from published raw metagenomic shotgun sequencing data and metadata, and enabling re-use of existing data
by a much broader range of researchers and methodologies. The proposed research is innovative because it
identifies and corrects important deficiencies in how microbiome data are published, increasing the utility of
public data and published results on a large scale by other research teams.

Public health relevance
Project Narrative The human microbiome is implicated in the development and response to treatment of some cancers, including infectious agents estimated to be responsible for ~20% of the global cancer burden. However, previously unrecognized bacterial and viral strains, as well as loss of normal structure and function of human-associated microbiomes, likely play additional roles in disease etiology and treatment. This project investigates the role of the human microbiome in cancer by applying novel and state-of-the-art methods to published metagenomic data, and provides enhanced, expanded, and more efficiently usable microbiome data resources back to the cancer research community for a broad range of investigations.